Development and characterization of germline-targeted nanoparticle immunogens toward a novel HIV Env epitope

Project Summary
Despite concerted efforts to develop an effective vaccine over the last 40 years, the HIV pandemic
remains a profound global public health challenge, with 75 million people infected and an estimated 32 million
deaths from AIDS-related illnesses since 19811. The discovery of patient-derived broadly-neutralizing
antibodies (bnAbs) has raised hopes that the immune system is capable of producing antibodies that might
prevent HIV-1 infection2. However, efforts to elicit similar antibodies through vaccination schemes have been
stymied, likely due to the combination of requirements for rare precursors, extensive somatic hypermutation
(SHM), and uncommon heavy-chain complementarity determining region 3 (CDRH3) lengths in previously
targeted bnAbs2.
Recently, a novel epitope centered on the heavily glycosylated “silent face” (SF) of gp120 was found to
be targeted by multiple antibodies derived from different germlines that were capable of cross-clade
neutralization of tier 1, 2, and 3 HIV-1 viruses3–5. Importantly, the two glycans that form a majority of the SF
epitope are >85% conserved, suggesting that antibodies targeting this epitope can in theory achieve
neutralization breadths comparable to bNAbs against the highly-conserved CD4 binding site. Importantly, the
relatively limited SHM (~20% amino acid) and ability to arise from multiple germlines in different donors
suggests that SF-targeting antibodies may represent a more achievable target for elicitation via
germline-targeting vaccination approaches; additionally, these antibodies also possess a complementary
breadth and potency to the more well studied V3-targeting bnAbs making them an attractive addition to a
potential poly-epitope targeted vaccine immunogen.
Thus, the central goal of this proposal is to develop HIV-1 Envelope (Env) trimer immunogens
capable of binding to the inferred germline versions of SF-targeting antibodies in vitro, which we
hypothesize will be capable of eliciting a primary B cell response to the SF epitope in vivo. To test this
hypothesis, I will (i) use yeast display to select for gp120 mutations that improve binding to SF-targeting
germlines, (ii) express these mutations in stabilized trimeric Env immunogens to decorate nanoparticle vectors,
and (iii) vaccinate knock-in mice transgenic for SF inferred germlines and characterize the naïve human B cell
response to our germline-targeting immunogens.
The long-term goal of this work is to validate the SF epitope as a target for germline-targeting vaccine
approaches. Further outcomes include a better understanding of the germlines capable of responding to this
epitope, which could help guide further rational immunogen design for an HIV vaccine.

Public health relevance
Project Narrative Decades of collective effort in the HIV field have led to a consensus that germline-targeting vaccine approaches offer one of the best methods for effectively eliciting broadly neutralizing antibodies. However, prior efforts have been hampered by the relative rarity and improbable maturation path of targeted precursors. By studying the human germline antibody response to the recently discovered “silent face” gp120 epitope and designing immunogens targeting these germline antibodies, this work will help guide and augment rational vaccine design efforts against HIV-1.